23rd International Workshop on Kaposi's Sarcoma Herpesvirus (KSHV) and Related Agents

ABSTRACT
The annual International Conference on Kaposi’s Sarcoma Herpesvirus and Related Agents will
bring together researchers and clinicians working on the oncogenic human herpesvirus,
Kaposi’s sarcoma herpesvirus (KSHV), and other closely related pathogens. KSHV is the
etiology agent of Kaposi’s sarcoma (KS), which is still one of the most prevalent cancers in
Africa, especially in HIV-1 infected individuals. The goals of these meetings are consistent with
the mission statements of the NIH, NCI, NIAID, and NIDCR, namely, to advance and promote
the pace of research on infections associated with human cancer and other diseases, including
in the setting of HIV-AIDS. The main KSHV conference will be held in Dar es Salaam, Tanzania,
from the afternoon of June 19 through June 22, 2023. With an additional day, June 23, for a
training workshop to engage both established researchers and trainees, clinicians and basic
researchers, to interact and develop collaborations on translational research projects. The
majority of the costs for the conference will be raised from registration fees paid by the
conference attendees and contributions from host institutions, foundations, and pharmaceutical
and biotechnology companies. The major focus of the KSHV meeting is the biology of
oncogenic herpesviruses and associated human diseases, with specific emphasis on viral
pathogenesis, viral latency and reactivation, viral gene expression and replication, host
responses to infection, epidemiology, vaccine development, therapeutic intervention, clinical
and translational research. In addition to KSHV, studies related to herpesvirus saimiri (HVS),
murine herpesvirus-68 (MHV-68), and rhesus rhadinovirus (RRV) will be presented. This
administrative supplement grant application requests funds to supplement the R13 award
(7R13CA250288) received for the conference which was supposed to be held in 2020. The
reason for the delay to 2023 was due to COVID-19. The supplement is needed because of the
awarded amount ($5,000) will be needed to cover the rising inflation cost of the planned
conference site which cannot be covered by the registration fees. The requested supplement
funds will be used to reduce the conference registration and partial travel costs for outstanding
pre- and post-doctoral trainees, historically under-represented minorities, and scientists from
lower- and middle-income countries, especially those from Africa who study oncogenic DNA
viruses and the cancers associating with these viruses.

Public health relevance
Narrative KSHV is a herpesvirus, driving a variety of malignancies and lymphoproliferative disorders, including Kaposi’s sarcoma (KS), primary effusion lymphoma, multicentric Castleman’s disease and KSHV-inflammatory cytokine syndrome (KICS). These cancers are more frequent in patients with HIV-AIDS and other forms of immunosuppression, and therefore are prevalent in specific geographical with high levels of endemic viral infection. Despite better control of HIV/AIDS, KSHV disorders produce significant morbidity and mortality, and KS continues to be one of the most common cancers in sub-Saharan Africa, emphasizing the need for better therapies prevention strategies against diseases with a KSHV etiology.